Diversity Supplment to P20 SUCCEED (5P20CA264068-02) for Chelsey Cooper

PROJECT SUMMARY
Abstract of Parent Grant and Pilot Project 2.
The overarching goal of the Virginia State University (VSU)-Virginia Commonwealth University (VCU) Massey
Cancer Center (MCC) PartnErship for Cancer Disparities Research and Training (SUCCEED) program is to lead
in the transformation of cancer-related outcomes for Virginians and to serve as a model of transdisciplinary
disparities research. The institutions will jointly conduct pilot research projects addressing local, cancer-related
health disparities, and will develop a training program for VSU faculty and students designed to attract and
prepare investigators for careers in cancer disparities. Researchers from VSU, a Historically Black College or
University, and (VCU) MCC understand the importance of collaboration and resources of both intuitions to
educate young adults who will help with the decline of colon cancer disparities in Virginia. A part of the parent
grant, Pilot Project 2 fills a gap in translational cancer disparities research by leveraging a promising screening
intervention, Screen to Save (S2S) to develop and test an enhanced mobile health (mHealth) S2S intervention
culturally tailored for AA men. Clinically, this is significant because AA men remain a dramatically underserved
group that has not equally benefited from existing CRC education or screening interventions.
Pilot Project 2 Specific Aim 1: Determine factors associated with self-reported CRC screening behaviors
among (n=175) AA men in Petersburg, VA.
Pilot Project 2 Specific Aim 2: Develop tailored S2S content for AA men to be delivered using a combination
of short video and text-based information optimized for delivery via QR codes for smartphones.
If this Research Supplement to Promote Diversity in Health-Related Research is awarded, Ms. Chelsey Cooper
will leverage the numerous resources at VSU, VCU, and MCC in her tailored training development plan and pilot
project. Given the cancer disparities training tenets within MCC, Ms. Cooper will have access to both coursework
and hands-on experience to continue to develop into an independent investigator with the tools and abilities to
compete for NCI NRSA or CURE funding. Her project will be focused on identifying psychosocial and
environmental barriers for CRC knowledge in African American young adults, which fits very well with the Parent
P20 Pilot Project 2 and the goals of the overall P20 SUCCEED initiative (5P20CA264068-02). Moreover, Ms.
Chelsey Cooper’s work is naturally and logically aligned with her mentorship team, Drs. Larry Keen (co-PI), Maria
Thomson (PI), and Michael Preston (co-I).
1

Public health relevance
PROJECT NARRATIVE The proposed diversity supplement will allow doctoral candidate Chelsey Cooper to receive training in biomedical research, intervention design, and cancer disparities through coursework and her pilot project which will determine the barriers to colorectal cancer health knowledge in young adult African American men. Results from this pilot project will further inform colorectal cancer knowledge interventions in the Petersburg, Virginia community; a community with extremely high rates of colorectal cancer and poor screening rates. The training Ms. Chelsey Cooper (Candidate) will receive over the course of two years will be critical for her career path in cancer disparities within the African American community. 1